Assessing RF heating of active implantable medical devices in low-field MRI system

!"#$%&'$(
!"#$#%&'%(%')#(*+%,$-.)"%&/%)"#%0'#%-1%&234(/)(54#%2#*&6(4%*#7&6#'%&/%)"#%89%(/*%,4-5(44+:%;-$#%)"(/%<=%2&44&-/%
>2#$&6(/'% 6($$+% (% 1-$2% -1% -$)"-3#*&6?% 6($*&(6?% -$% /#0$-2-*04()&-/% *#7&6#% (/*% )"#% /025#$% ,$-.'% 5+% <@@?@@@%
(//0(44+:%>)%4#(')%ABC%-1%)"#'#%3()&#/)'%.&44%/##*%2(,/#)&6%$#'-/(/6#%&2(,&/,%D;EFG%*0$&/,%)"#&$%4&1#)&2#?%.&)"%
2(/+%$#H0&$&/,%$#3#()#*%#I(2&/()&-/':%8/1-$)0/()#4+?%)"#%&/)#$(6)&-/%5#).##/%;EFJ'%$(*&-1$#H0#/6+%DEKG%1*'%
(/*% 6-/*06)&7#% &234(/)'% 6(/% 4#(*% )-% )"#$2(4% &/L0$&#'% *0#% )-% EK% "#()&/,?% 2(M&/,% ;EF% &/(66#''&54#% )-% 2-')%
3()&#/)':( E#6#/)4+?% 4-.N1*% ;EF% '6(//#$'% D@:BB% !% (/*% 5#4-.G% "(7#% ,(&/#*% )$(6)&-/% *0#% )-% $#*06#*% 6-')% (/*%
#('#% -1% '&)&/,:% O#6(0'#% 2#)(4% ($)&1(6)'% (/*% $&'M% -1% 2(,/#)&6% 1-$6#'% ($#% $#*06#*% ()% 4-.#$% 1*'?% )"&'% 64(''% -1%
'6(//#$'% ($#% .&*#4+% 3054&6&P#*% ('% &234(/)N1$&#/*4+% (45#&)% (5L#6)% 4(6M% -1% #7&*#/6#% -/% )"#&$% EK% '(1#)+:( !"&'% &'%
6-/6#$/&/,?% 5#6(0'#% (4)"-0,"% 9>E% )#/*'% )-% 5#% 4-.#$% ()% 4-.#$% 1*% ')$#/,)"'?% )"#% '6#/($&-% 6(/% *$(2()&6(44+%
6"(/,#% &/% )"#% 3$#'#/6#% -1% #4-/,()#*% &234(/)'% D'06"% ('% 4#(*'G%5#6(0'#% -1% )"#% (/)#//(% #11#6):% 93#6&1&6(44+?% -0$%
D0/3054&'"#*G% *()(% '"-.'% )"()% 03% )-% Q@@C( "&,"#$% EK% "#()&/,% 6(/% -660$% ($-0/*% 4#(*'% -1% (% 6($*&(6% -$% (%
/#0$-2-*04()&-/% *#7&6#% ()% @:BB% !% 6-23($#*% )-% <:B% !% ;EF% *#3#/*&/,% -/% )"#% 4#(*J'% 4#/,)":% O#6(0'#% 4-.N1*%
'6(//#$'%($#%/-.%KR>N(33$-7#*%1-$%64&/&6(4%0'#?%&)%&'%&23#$()&7#%)-%,#/#$()#%#7&*#/6#N5('#*%M/-.4#*,#%('%)-%
)"#&$%EK%"#()&/,%3$-1&4#%)-%3$#7#/)%0/&/)#/*#*%&/L0$&#'%)-%3()&#/)':%%
F/% *&$#6)% $#'3-/'#% )-% )"&'% /##*?% .#% 3$-3-'#% (% )-% 4#7#$(,#% -0$% #I3#$)&'#% &/% ;EF% 6-230)()&-/(4% 2-*#4&/,% (/*%
'(1#)+% (''#''2#/)% (/*% -0$% (66#''% )-% ')()#N-1N)"#N($)% *##3% 5$(&/% ')&204()&-/% DRO9G% (/*% 6($*&-7('604($%
&234(/)(54#%#4#6)$-/&6%*#7&6#'%DSFTR'G%)-%3#$1-$2%(%$&,-$-0'%(/*%0/5&('#*%#7(40()&-/%-1%EK%"#()&/,%-1%RO9%(/*%
6($*&(6% *#7&6#'% *0$&/,% ;EF% ()% @:BB% !:% 93#6&1&6(44+?% .#% .&44% (0,2#/)% -0$% #I&')&/,% $#3-'&)-$+% -1% 3()&#/)N*#$&7#*%
&234(/)%2-*#4'%)-%&/640*#%2-*#4'%-1%3#*&()$&6%(/*%(*04)%3()&#/)'%.&)"%SFTR'?%(/*%3#$1-$2%#4#6)$-2(,/#)&6%(/*%
)"#$2(4% '&204()&-/'% )-% 6(4604()#% EK% "#()&/,% -1% )"#'#% *#7&6#'% *0$&/,% ;EF% ()% @:BB% !% D0/4(5#4#*G% (/*% 6-23($#% &)%
.&)"%EK%"#()&/,%,#/#$()#*%5+%(%<:B%!%'6(//#$%D4(5#4#*G:%U#%.&44%)"#/%*#7#4-3%(,#N'3#6&1&6%(/*%*#7&6#N'3#6&1&6%
4--M03%)(54#'%)"()%(44-.%'#4#6)&-/%-1%&2(,&/,%3($(2#)#$'%)"()%6-/')$(&/)%EK%"#()&/,%*0$&/,%;EF%()%@:BB%!:%
V0$%)#(2%&/640*#'%#I3#$)'%&/%;EF%3"+'&6'%(/*%'(1#)+?%64&/&6&(/'%.&)"%#I3#$)&'#%&/%3#*&()$&6%#4#6)$-3"+'&-4-,+%(/*%
*#7&6#% &234(/)()&-/?% ('% .#44% ('% &/*0')$&(4% 3($)/#$'% &/% ;EF% (/*% 2#*&6(4% *#7&6#':% !"#% -0)6-2#% -1% -0$% .-$M% .&44%
,#/#$()#%)"#%1&$')%5-*+%-1%M/-.4#*,#%-1%EK%"#()&/,%-1%#4#6)$-/&6%&234(/)'%()%4-.N1*%;EF?%(/*%3$-7&*#%)"#%5('&'%
1-$% #7&*#/6#N5('#*% (''#''2#/)% -1% $&'MN5#/#1&)% $()&-% -1% ;EF% #I(2':% R&,&)(4% 2-*#4'% -1% 3#*&()$&6% (/*% (*04)'%
*#7#4-3#*% &/% )"&'% .-$M% .&44% 5#% 2(*#% 3054&64+% (7(&4(54#% )-% 3$-7&*#% (% -/#N-1N(NM&/*% *()(5('#% 1-$% '&204()&-/% (/*%
2-*#4&/,%&/%10)0$#%(334&6()&-/':(

Public health relevance
Narrative This project aims to develop computational methodologies that for the first time quantify RF heating of deep brain stimulation devices and cardiac electronic implants during low-field magnetic resonance imaging (MRI) at 0.55 T. Results will produce data that allow determination of safe imaging parameters, and support development of standards and imaging guidelines which bring MRI accessible to these patients.